DIABETES PREVENTION TRIAL TYPE I DIABETES (DPT-I)

This study is part of an NIH funded, multicenter diabetes prevention trial. The major objective of the DPT-1 is to determine whether early intervention by anti-gen based therapies in non-diabetic relatives of persons with type 1 insulin-de-pendent diabetes mellitus (IDDM) can delay their development of IDDM as a clini-cal disease.